MATING INDUCED DOWN REGULATION OF PROGESTIN RECEPTORS

Activation of steroid receptors regulates gene transcription which causes changes in neuronal activation and ultimately behavior, therefore an understanding of cellular processes regulating steroid receptor concentrations has clinical importance. A recent study has shown that mating causes down-regulation of progestin receptors in some brain areas. Mating-induced potentiation of lordosis in estrogen-primed female rats appears to be the result of ligand- independent activation of progestin receptors, because the effect can be blocked by a progesterone antagonist in the absence of progesterone. It is hypothesized that mating-induced down- regulation of progestin receptors is also mediated by ligand- independent activation of progestin receptors. In the present series of experiments, the cellular mechanisms mediating mating- induced down-regulation of progestin receptors will be explored. In addition, these experiments will provide more extensive training in steroid receptor immunocytochemistry, training in intra- cerebroventricular administration of drugs, and training in in situ hybridization.